Mechanisms of Macroglossia in Beckwith-Wiedemann Syndrome

PROJECT SUMMARY/ABSTRACT
Macroglossia (severe tongue overgrowth) leads to catastrophic morbidity and mortality in infants with
Beckwith-Wiedemann Syndrome (BWS). Respiratory distress and airway obstruction are often present
at birth, and the only current treatment is surgical resection of the tongue. Surgery can have significant
side effects, including risk for lingual nerve injury and infection and is not always curative. Tongue
muscle is considered to be similar to skeletal muscle, but in-depth analysis is currently limited in both
human and mouse models. Several other skeletal muscle diseases have been linked to defective
signaling in satellite cells and the interaction between specific muscle cell types. The specific signaling
pathways causing macroglossia have not been defined. There are two critical genes altered in BWS
that may play a role in tongue overgrowth (Cyclin dependent kinase 1C (CDKN1C) and/or Insulin-like
growth factor 2 (IGF2)). Clinical observation of hundreds of patients with BWS suggests that the
macroglossia phenotype can be divided based on the increased state of IGF2 versus decreased state
of CDKN1C in each patient. This work will focus on how the genetic changes seen in BWS lead to
distinct BWS tongue phenotypes based on the cell composition, expression, and function of these BWS
genetic subtypes. We have the largest collection of BWS tongue samples in the United States, including
tongue samples with alterations in each of these genes, which will allow us to study the contribution of
each gene to macroglossia. Through our collaborative research team, we have assembled the
expertise to define the cell types, cellular drivers and the pathways causing macroglossia. Our approach
includes single-nuclei transcriptomic analysis of cell composition and interaction and in situ analysis of
the interface between the key cell types through immunohistochemistry. We will separate these cell
types in the tongue through sorting and characterize satellite cell proliferation and differentiation
potentials based on their genetic alterations (IGF2HIGH, CDKN1CLOW, IGF2HIGH+CDKN1CLOW). Finally,
we will define the in vivo role of the satellite cells from the different BWS subtypes (IGF2HIGH,
CDKN1CLOW, IGF2HIGH+CDKN1CLOW) in a xenograft tongue model. This proposal will define the cell
composition and cell-specific contributions to tongue overgrowth at the individual and the organ level.
This work represents a critical step towards developing targeted non-surgical therapeutics for infants
with BWS and macroglossia along with related muscle diseases.

Public health relevance
PROJECT NARRATIVE Macroglossia (severe tongue overgrowth) leads to extreme difficulty in breathing and feeding for infants with Beckwith-Wiedemann Syndrome. This research will define the specific cell types, cell-specific signaling and properties, and the interactions between cells in the tongue which drive tongue overgrowth and will allow us to develop noninvasive, targeted treatments. These mechanisms, which also drive normal muscle growth, may be harnessed for treatment of diseases that cause muscle loss, as well as to better understand postnatal muscle development.